Treating flaviviruses with mRNA-encoded Cas13

Project Summary
Flaviviruses are vector-borne, positive-stranded RNA viruses that emerge unexpectedly and cause a spectrum
of potentially severe diseases including hepatitis, vascular shock syndrome, encephalitis, paralysis, and
congenital abnormalities. During the last 70 years, Dengue (DENV), West Nile virus (WNV), and Zika virus (ZIKV)
epidemics have occurred globally, and flaviviruses infect over 400 million people annually. Despite extensive
research, there are currently no FDA approved antivirals available for any flavivirus infection. Vaccines exist for
Japanese encephalitis virus (JEV), Yellow Fever virus (YFV), and tick-borne encephalitis virus (TBEV); for
Dengue, Dengvaxia is for those previously infected, and Qdenga has received EU approval for all populations.
However, due to poor efficacy, low vaccination rates and sequence variability, cases due to flaviviruses still
remain high, justifying the need for antiviral development. Current antiviral drug development is focused on small
molecules and neutralizing antibodies, which require high doses or frequent re-dosing to obtain functional
outcomes; their efficacy has been challenged by virus sequence variations. Thus, it is crucial to address the
need for higher efficiency and broader spectrum antivirals. To address this need we are proposing a new
paradigm for antiviral development, a mRNA-encoded activatable RNase, Cas13, as a platform for flavivirus
treatment. Cas13 represents a programmable RNase that can directly target and degrade multiple viral RNAs.
Synthetic mRNA and lipid nanoparticles are being used to deliver the RNase, as it allows for transient, non-viral
delivery, with an improved safety profile over other gene therapy vectors. To date, our team was the first to
demonstrate efficacy of mRNA-encoded Cas13 in vivo against influenza and SARS-CoV-2 in our recent
publication in Nature Biotechnology. We also have preliminary data demonstrating single-dose efficacy using
mRNA-encoded Cas13 with DENV-2 via systemic LNP-based delivery. Our long-term goal is to generate a suite
of mRNA-encoded Cas13 drugs against pathogenic flaviviruses. Our short-term goal is to demonstrate targeting
of multiple flaviviruses, including DENV, WNV, ZIKV, Powassan and YFV, further investigate the mechanism of
action of Cas13, and demonstrate in vivo efficacy against DENV 1-4 and WNV.

Public health relevance
Narrative The overarching goal of this application is to develop mRNA-encoded Cas13 based drugs for treating flaviviruses, with a focus on dengue and West Nile virus, but including screens against yellow fever, Powassan and Zika viruses. Multiple Cas13 nucleases will be evaluated, and mechanisms of action investigated; efficacy will be demonstrated with dengue (serotypes 1-4) and West Nile virus in rodent infection models. Overall, we feel this approach and the RNA-based platform have the potential to alter the paradigm for how viral infections are treated.